ALACRITY for Early Screening and Treatment of High Risk Youth (eSToRY)

PROJECT SUMMARY/ABSTRACT- Cambridge Health Alliance
ALACRITY for Early Screening and Treatment of High Risk Youth (eSToRY)
Barriers to quality mental health care for youth at risk of mental illness are well recognized but persistent,
especially among racial, ethnic, and language (REL)-minority youth. The proposed Center for Early Screening
and Treatment of at-Risk Youth (the eSToRY Center) is dedicated to research and training to improve early
detection of mental illness, to prevent adverse outcomes, to improve quality of care, and to foster equity in
treatment for REL-minority youth. The eSToRY Center is designed to identify interventions that close mental
health care access and treatment quality gaps among REL-minority youth. Through a strong web of
community-based connections, we will: a) collect and analyze real-time clinical and sociocontextual information
via an integrated data warehouse of adaptive symptom monitoring (CAT-MH), electronic health records (EHR),
insurance claims, and community data; and b) plan and manage the rollout and testing of measurement-based
mental health care.
Our proposed projects span community and healthcare system settings, recognizing the need to improve
access to treatment and quality of care once treatment is realized for REL-minority youth. In Aim 1, we develop
effective community-based outreach and screening programs to identify, refer and provide early interventions,
to youth at risk for developing mental illnesses. In Aim 2, we rigorously test and implement healthcare system-
based targeted interventions to prevent the development of mental illness and suicide in REL-diverse youth. In
Aim 3, we establish a Center for developing and testing innovative interventions to reduce disparities in access
and treatment for REL-minority youth and translating findings directly into clinical practice.
To accomplish these aims, we will create: an Administrative Core that oversees pilot studies, conducts training,
and promotes community participation; a Methods Core that leverages adaptive psychopathology screening
and social determinants of health screeners, implements rigorous randomized controlled trials, and conducts
predictive analytics to inform efforts to reduce disparities; three research projects that improve the identification
and early treatment of psychopathology, suicidality, and traumatic experiences among REL-diverse youth.

Public health relevance
PROJECT NARRATIVE- Cambridge Health Alliance ALACRITY for Early Screening and Treatment of High Risk Youth (eSToRY) Barriers to quality mental health care for youth at risk of mental illness are well recognized but persistent, especially among racial, ethnic, and language (REL)-minority youth. The proposed Center for Early Screening and Treatment of at-Risk Youth (the eSToRY Center) is dedicated to research and training to improve early detection of mental illness, to prevent adverse outcomes, to improve quality of care, and to foster equity in treatment for REL-minority youth. We leverage a sophisticated health data infrastructure and an interdisciplinary team of experts to adapt, test, and implement evidence-based practices to accelerate mental health care improvements for REL-minority youth populations.